ASSESSMENT AND USE OF NEW ULTRASONIC TECHNOLOGIES

New modes of Doppler ultrasound and new signal conditioning of the received sonic spectra permit accurate assessments of velocities of intracardiac blood flow. Color-encoded, two-dimensional Doppler permits qualitative and quantitative evaluations of entire flow field velocity patterns. Studies utilizing these technologies include the following: 1) Doppler velocity/flow mapping in vivo and in vitro of clinical and preclinical prosthetic mitral valves; 2) comparison of in vivo Doppler ultrasound with in vitro Doppler ultrasound and laser Doppler anemometry; 3) assessment of mitral regurgitation; 4) quantitation of obstruction and regurgitation in right ventricular to pulmonary artery conduits. Studies in patients, both intraoperatively and postoperatively, have been initiated for assessment of operations for valvular lesions.